Exposure to Ambient Air Pollutants, Circulating microRNAs, and Hepatic Fat Fraction Among Young Adults

PROJECT SUMMARY
Applicant. The long-term research goal of the F31 fellowship applicant, William B. Patterson, is to implement
advanced statistical modeling approaches to study the biomolecular mechanisms linking environmental
exposures and human metabolic diseases. He will be mentored by Drs. Tanya Alderete and Andrea Baccarelli
during the training period. Significance. Non-alcoholic fatty liver disease (NAFLD) elevates the risk for
cardiometabolic diseases and is increasing in prevalence and severity among adolescents and young adults.
Animal and cell-based models suggest that ambient air pollution (AAP) exposure may contribute to NAFLD risk
by inducing changes to the expression of circulating microRNAs (miRNAs), a class of non-coding RNAs that
regulate gene expression. Circulating miRNA profiles are altered during the onset and progression of NAFLD
and in the context of environmental exposures and can serve a “liquid biopsy” that can enable non-invasive
insight into exposure and organ-specific pathogenesis. Therefore, circulating miRNAs may represent an
important non-invasive mechanistic biomarker of air pollution exposure and NAFLD risk, yet this hypothesis has
not yet been studied in humans. Thus, the aim of the current study is to examine associations of AAP exposure
with circulating levels of miRNAs and liver fat accumulation among young adults from the Meta-AIR cohort, which
is a subset of the Children’s Healthy Study. Aim 1. Determine whether higher AAP exposure is associated
hepatic fat fraction and/or NAFLD via whole abdominal MRI scans. Aim 2. 2a) Identify miRNA profiles associated
with higher AAP exposure 2b) Determine whether target genes of miRNAs associated with AAP are enriched in
metabolic pathways known to play a role in hepatic lipid accumulation. Aim 3. Perform a structural integrated
analysis to identify subgroups of young adults that are at risk for NAFLD by testing if AAP exposures and miRNA
profiles can predict those with and without NAFLD. Approach. This project will address a shortcoming of
previous human exposure studies that have relied on liver enzymes as a proxy for NAFLD by examining hepatic
fat fraction from whole abdominal MRI scans and will leverage existing miRNA data from 144 young adults. Aim
3 will employ an innovative tool, LUCID, for integration of exposure and miRNA profiles. During the F31 research
and training period, the applicant will acquire significant training in environmental epidemiology and epigenetics
research methods. Study results may have important public health implications aimed at reducing AAP exposure
and may provide novel insight into clinically relevant clusters of young adults with increased risk for NAFLD given
their individual AAP exposure and miRNA profiles. In addition, miRNA inhibitors are increasingly part of
therapeutic development and thus important miRNAs identified in this work could provide targets to interrupt the
pathways that sustain NAFLD pathophysiology. This proposal is aligned with the NIEHS Strategic Plan “Goals
for Advancing Environmental Health Sciences”, particularly the Big Science and Big Data goal which emphasizes
utilization of innovative approaches for big data integration.

Public health relevance
PROJECT NARRATIVE Higher exposure to ambient air pollution (AAP) is believed to increase the risk for non-alcoholic fatty liver disease (NAFLD), a pernicious disease which currently lacks robust non-invasive diagnostic biomarkers and has limited treatment efficacy. Circulating microRNAs, which regulate gene expression, are sensitive to environmental exposures and are dysregulated during the onset and progression of NAFLD and thus may hold potential as a non-invasive mechanistic biomarker. The proposed aims will advance the scientific knowledge of air pollution health effects in an understudied demographic of young adults and may provide novel insight into clinically relevant clusters of individuals with increased risk for NAFLD given their AAP exposure and microRNA profiles.